Non-Invasive Imaging Biomarkers to Identify a High-Risk Chronic Kidney Disease Phenotype

PROJECT SUMMARY
Patients with chronic kidney disease (CKD) are at increased risks of developing cardiovascular disease,
progressing to end stage renal disease, and dying prematurely. Translation of scientific breakthroughs into
clinical trials is limited by our ability to identify the right study population. By assessing the degree of interstitial
fibrosis/tubular atrophy (IFTA), global glomerulosclerosis (GS), and microvascular disease (MVD), kidney
histopathology informs risk of CKD progression, independent of estimated glomerular filtration rate (eGFR) and
proteinuria. Prior studies implicate decreased renal microvascular perfusion and resultant chronic hypoxia in
the pathogenesis of renal fibrosis. Since kidney biopsy carries risks, investigation of a novel imaging biomarker
of renal microvascular perfusion may provide a non-invasive tool to identify a high-risk CKD phenotype. By
assessing the motion of intravascular microbubble contrast agents, contrast enhanced ultrasound (CEUS) may
detect renal microvascular perfusion. In exciting preliminary data, Dr. Srivastava found a low microbubble
wash-in rate, suggestive of low renal microvascular perfusion, in patients with advanced CKD and with severe
chronic histopathologic lesions. In the proposed studies, he will comprehensively evaluate the microbubble
wash-in rate in health and disease. In Aim 1, he will test the association of the microbubble wash-in rate with
gold standard assessments of renal blood flow and function, measured by para-aminohippurate and iohexol
clearances, respectively. In Aim 2, he will use the microbubble wash-in rate to differentiate patients with CKD
from healthy volunteers. In Aim 3, he will test the association of the microbubble wash-in rate with MVD, IFTA,
GS, and change in eGFR over time in individuals undergoing a native kidney biopsy. The results will inform the
field of novel non-invasive imaging biomarkers in CKD. Complementary to the highly clinically relevant studies,
Dr. Srivastava will implement a strategically focused career development plan 1) to acquire skills in image data
analysis and development of imaging biomarkers, 2) to incorporate imaging biomarkers into patient oriented
research studies, 3) to learn methods to perform imaging biomarker validation, 4) to develop scientific
management skills and build collaborations with biomarker and imaging experts, and 5) to increase research
portfolio and improve grantsmanship skills. To accomplish these goals, Dr. Srivastava assembled a multi-
disciplinary mentoring team of experts in patient oriented research and clinical trials in CKD (Primary mentor,
Dr. Tamara Isakova), CEUS (Co-mentor, Dr. Thomas Grant), biomarker development and validation (Dr.
Sushrut Waikar), CEUS image analysis (Dr. Jason Streeter), flow imaging (Dr. Michael Markl), and patient
oriented research with imaging endpoints (Dr. James Carr). Execution of the proposed studies, acquisition of
the training goals, and outstanding mentorship in a robust scientific environment at Northwestern University will
position Dr. Srivastava to transition to an independent investigator with unique expertise in use of novel non-
invasive imaging biomarkers in patient oriented research studies and clinical trials in patients with CKD.

Public health relevance
PROJECT NARRATIVE Reductions in kidney blood flow can lead to permanent damage to the kidneys, known as chronic kidney disease, which can progress to complete loss of kidney function and can shorten life span. We propose to investigate whether information about kidney blood flow that we will obtain from contrast enhanced ultrasound will help identify which individuals with chronic kidney disease are at high risk of experiencing progressive loss of kidney function. The high-risk individuals can then be included in future clinical trials to test new treatments for chronic kidney disease.